Preclinical Core

Preclinical Core Abstract
The Preclinical Core (PC) provides IDDRC investigators with innovative, advanced approaches to conduct
research spanning fine-grained resolution at the molecular and cellular level, to regional neurocircuitry and
connectivity across brain, to multi-domain characterization of mouse behavior. In this application, 40 projects
from 21 IDDRC investigators are proposed for core access in studies using models of ADHD, Angelman
syndrome, ASD, childhood ataxia, epilepsy, intellectual disability, Joubert syndrome, Pitt-Hopkins syndrome,
Rett syndrome, and other neurodevelopmental disorders. The PC has three components, the Mouse
Behavioral Phenotyping Laboratory, the Neuroscience Microscopy Facility, and the Small Animal Imaging
Service, which, together, offer a broad range of resources and expertise for multidisciplinary IDD research.
Services include consultation with expert core faculty, an extensive battery of mouse behavioral testing,
training in cutting-edge microscopy methods, acquisition and analysis of quantitative MRI data, and access to
state-of-the-art laboratory facilities. A critical goal for the Core is to facilitate projects integrating
complementary approaches, such as microscopy analysis of cortical architecture and behavioral evaluation of
cognitive phenotypes, to enhance understanding of underlying pathophysiology and structure-function
relationships in neurodevelopmental disorders. Within the IDDRC, the PC partners with the Clinical
Translational Core and Data Science Core around the use of machine-learning approaches and the
establishment of automated data-processing pipelines for new methods development. Overall, the PC
provides expertise and infrastructure that has become essential for our IDDRC research using preclinical
models, with the overarching aim of supporting breakthrough, transformative science in diagnosis, prevention,
and treatment of developmental disorders.
1